Type II alveolar epithelial cell-intrinsic IL-1 response in protective immunity against tuberculosis

PROJECT SUMMARY/ABSTRACT
Interleukin-1 (IL-1) plays an important role in the host defense against Mycobacterium tuberculosis (Mtb), the
bacterium that causes human disease tuberculosis (TB). IL-1 is essential for anti-bacterial immunity during Mtb
infection in mice and genetic polymorphisms in IL-1 receptor (IL-1R1) signaling are associated with greater risk
from active pulmonary TB. IL-1R1 is expressed by both the hematopoietic-derived and stromal cells in the lung,
but the cell-type specific roles of IL-1R1-signaling in protective immunity against TB remains unclear.
Supported by a R56 Bridge grant from NIAID, we investigated the contribution of different lung cells to the IL-
1R1 mediated protective immunity. We used bone marrow chimaeras and discovered that IL-1R1 expression
on stromal cells is crucial for protecting mice against severe disease. We generated a panel of knock-in and
knock out mouse strains where IL-1R1 expression is conditionally deleted- or restored in specific cells either
in a wild type or IL-1R1-deficient host background. Our preliminary results indicated that expression of IL-1R1
on type II alveolar epithelial cells (AECII) is both necessary and sufficient for controlling bacterial replication,
inflammation in the lung and preventing wasting disease. AECII-intrinsic IL-1R1 signaling is critical for anti-
mycobacterial immunity and preventing type I IFN (IFN-I) dependent neutrophil influx. Depleting neutrophils or
IFN-I significantly reduced bacterial load, immunopathology. Moreover, AECII-restricted overproduction of GM-
CSF in the lung protected the highly susceptible GM-CSF deficient animals by reducing bacterial load, weight
loss and lung pathology. Importantly, IFN-I blockade rescued alveolar type I (AEC-I) and type II (AECII)
epithelial cells that were otherwise damaged during progressive disease. Based on our preliminary results, we
hypothesize that IL-1R1 signaling in AECII potentiates the anti-microbial function of myeloid cells by GM-CSF
production and restrains the pathological level of IFN-I production to maintain epithelial barrier integrity. We
have three specific aims. In aim1, we will investigate the role of GM-CSF in regulating antimicrobial immunity
by examining bacterial fitness and replication dynamics in myeloid cells obtained from mice that lack or express
IL-1R1 expression in AECII. In aim2, we will investigate the role of AECII-derived prostaglandin E2 (PGE2) in
regulating IFN-I response and consequent pathogenic neutrophil influx to prevent tissue damage. Finally, in
aim3, we will investigate the impact of IFN-I on alveolar epithelial cell repair and regeneration by performing
lineage tracing and spatial analysis of lung epithelial cells in the infected lung samples. Overall, the completion
of these aims will provide mechanistic basis for IL-1R1 mediated protective immunity and reveal principles to
target airway epithelial cells for boosting antimicrobial immunity and limiting the inexorable lung damage
caused during TB that contributes to lung function impairment in patients even after antibiotic therapy.

Public health relevance
PROJECT NARRATIVE Pulmonary tuberculosis caused by Mycobacterium tuberculosis (TB) is one of the top causes of mortality and morbidity from infectious diseases. With the ongoing COVID19 pandemic, TB care has been severely compromised across the globe, resulting in a sharp increase in mortality and morbidity. The proposed research is relevant to public health as it seeks to understand how alveolar epithelial cells in the lung communicate with innate immune cells to mediate early protection from TB and identify mechanisms that compromises these protective immune responses resulting in disease progression. The knowledge to be gained will have direct implications in designing therapeutics or vaccines to target such mechanisms to boost TB immunity.